The impact of delivery hospital organizational structure and culture on perinatal outcomes

PROJECT SUMMARY
Adverse outcomes for pregnant patients and infants associated with the hospitalization for childbirth are
frequent and vary across hospitals in the United States. Organizational factors, such as organizational
structure and culture, in birth hospitals are potential drivers of variation in care and outcomes. Maternal and
neonatal levels of care, an organizational structure, are the risk-based services available at a hospital for
mothers and infants, respectively. Organizational culture refers to the beliefs, perceptions, and values on
obstetric and neonatal units in a hospital, a key component of which is the culture of patient-centered care. The
care and health of the mother and infant are interrelated, yet studies have not formally assessed perinatal
organizational factors, those created by the intersection of maternal and neonatal care at the hospital level.
The overall objective of this study is to determine how organizational factors of obstetric and neonatal
units, formalized by this proposal as perinatal profiles of organizational structure and culture, impact perinatal
outcomes of mothers and infants and drive hospital variation. Dr. Handley will achieve this objective by 1)
assessing the impact of perinatal level of care profiles, 2) assessing the impact of perinatal patient-centered
care culture profiles, and 3) examining the interaction of perinatal structure and culture profiles on perinatal
outcomes. Her analysis will leverage a nine-state, retrospective cohort of mother-infant pairs as well as primary
data from her organizational culture survey of California birth hospitals, which will be linked with state data to
produce a novel dataset.
This proposal was designed to prepare Dr. Handley to become an independent investigator, specifically
focused on integrating health services research and organizational science in order to understand how
organizational factors on obstetric and neonatal units affect perinatal outcomes. Her research will be
complemented by training in advanced statistical methods for observational data and primary organizational
culture survey data as well as acquiring in-depth knowledge of organizational behavior, dynamics, and change.
Working with a multidisciplinary team of mentors and advisors with experts from neonatology, health care
management, obstetrics, and biostatistics will provide her valuable guidance in the completion of this work and
planning of future studies.
Understanding the implications of perinatal organizational structure and culture profiles on perinatal
outcomes is critical to improving perinatal care. Through better understanding of drivers of outcome variation
across hospitals and identification of organizational factors amenable to change, this work has the potential to
shape perinatal level of care policies, inform initiatives to improve organizational culture and coordination of
maternal and neonatal care, and guide future change at the hospital, state, and national levels, which are
actionable strategies to improve outcomes of the mother-infant dyad.

Public health relevance
PROJECT NARRATIVE This proposal seeks to understand the impact of perinatal organizational factors, those created by the intersection of maternal and neonatal care in birth hospitals, on the care and health of mothers and infants. Focusing on the organizational structure of level of care (the risk-based services available at a hospital for mothers or infants) and the organizational culture of patient-centered care (the extent to which care is respectful of, and responsive to, individual patient preferences, needs and values), I will assess whether and how these factors interact to influence perinatal outcomes. Understanding the implications of perinatal organizational structure and culture is critical to improving the care and outcomes for the more than 3.5 million mothers and their infants who are born in the United States each year.